ACTG 265--LIVE ATTENTUATED VARICELLA VACCINE IN HIV INFECTION CHILDREN

CHOP has enrolled one child in this study to date. Nationwide, this study has reached almost complete accrual, however data collection will continue for 3 years after immunization. We anticipate enrolling 1 additional child at our site within the next month. No preliminary data are yet available from enrolled subjects.